STUDIES IN MATHEMATICS AND STATISTICS

We have continued work on projects related to the theory of reaction rates for chemical reactions. Present projects include the study of statistical properties of the displacement of diffusing particles in a field of static traps, and the theory of survival times of particles in a field of static traps subjected to time-varying forces. A second project relates to the microscopic kinetics of entangled polymers. Together with Dr. Szabo we are writing a review of first passage time problems in chemical physics.